A Highly Precise Platform Technology for Controlling Diverse Clinical Targets in Addiction

Project Summary
Addiction is a debilitating disorder that affects ~20 million people and incurs an annual economic burden of $740
billion in the United States alone. However, despite intensive drug discovery efforts, we still lack highly effective
therapies for addiction, emphasizing the need for a better understanding of the pathophysiology of the disease
and a paradigm-shift in drug design. Towards this end, recent technological advances in neuroscience have
allowed us to interrogate the neural circuits that underlie addiction with high precision. We can map the spatial
organization of neural circuits, detect and manipulate the firing of selected neurons, and measure the dynamics
of neural signal release. However, what is missing is a deep understanding of the molecular effects of neural
signals once they are released — rather than simply connecting one neuron to another, neural signals encode
complex information by controlling multiple, functionally distinct receptors and their various downstream signaling
molecules at once. For example, the neuromodulator dopamine plays key roles in addiction by dynamically
activating five G protein-coupled dopamine receptors, which have diverse functions across the brain and
periphery, engage numerous downstream signaling proteins, and are associated with varying clinical potential
and risk. Thus, the next frontier in addiction research is to uncover the functional role and therapeutic value of
specific populations of neural signaling proteins. The goal of this proposal is to develop and apply a highly precise
platform technology called Tag-Guided Drug to better understand the functional role of selected populations of
neural signaling proteins in addiction. Tag-Guided Drug combines the doseability and reversibility of conventional
drugs with the molecular, spatial, and cellular specificity of genetic targeting. We developed a Tag-Guided Drug
for dopamine D2 receptor, a putative target for treatment of addiction. We will use the D2R Tag-Guided Drug to
better understand the functional role of D2 receptor in a mouse model of cocaine addiction and, in parallel,
develop a pipeline for generating Tag-Guided Drugs for other clinically relevant neural signaling proteins,
including various G protein-coupled receptors (GPCRs) and intracellular signaling proteins. Overall, Tag-Guided
Drug is highly innovative and has major implications for neuroscience, addiction, and biological sciences as a
whole.

Public health relevance
Project Narrative Addiction is a debilitating disorder that affects ~20 million people and incurs an annual economic burden of $740 billion in the United States alone. Unfortunately, intensive drug discovery efforts have largely failed to stem the rising toll of addiction, underscoring the need for a better understanding of this disease and a paradigm-shift in drug design. We propose to develop a new platform technology that could allow us to control diverse proteins with molecular and spatiotemporal precision, greatly enhancing our ability to study and treat addiction and other central nervous system disorders.